Hippocampal dopamine signaling and food-related memory: implications for obesity

Project Summary/ Abstract
Dopamine (DA) is a neurotransmitter associated with reward and reward-prediction based learning9.
One type of rewarding stimulus is the consumption of food which provides both orosensory and post-ingestive
positive feedback10; 11. In a modern society where food is both plentiful and more energetically dense, these
systems may also be involved in the etiology of obesity and overeating12; 13. In fact, research in human subjects
with obesity and obese rodent models has found that dopaminergic (DAergic) signaling machinery is
dysregulated compared to healthy subjects in key reward processing centers such as the nucleus accumbens in
the ventral striatum (ACB)14; 15; 16. The hippocampus (HPC), a brain region associated with memory function,
has also been implicated in the higher-order control of food intake17; 18. For example, humans with bilateral
HPC damage will eat multiple meals in rapid succession yet report little to no change in hunger or satiety11.
Further, primed verbal recall of a previous meal can reduce the consumption of a subsequent snack19; 20.
While not as widely studied as the midbrain DA pathway, the HPC also receives DAergic innervation
from VTA neurons associated with reward21; 22; 23. HPC neurons also express both major classes of DA receptors
rendering them able to respond to DA24; 25; 26. DA receptors have been shown to influence the synaptic plasticity
and firing patterns of HPC neurons, properties which are widely considered the molecular substrates for
memory formation26; 27. Human PET scan data revealed that DA is indeed released in the HPC following a
palatable meal, and in mice, manipulating the activity of DA receptor-expressing HPC neurons influences food
intake28; 29. Together, these data suggest that meal-induced DA signaling in the HPC may influence future food
intake, and that dysregulation of this system may contribute to obesity.
We hypothesize that elevated dHPC DA signaling upon eating serves to encode an episodic memory of
consuming a meal. Preliminary data presented herein reveal that HPC targeted DA type 2 receptor (D2R) but
not D1R blockade impairs meal location memory in male rats. Aim 1 experiments will investigate if this
phenotype is specific to food-specific memories, and if manipulation of these receptors influences food intake.
Other preliminary findings using in vivo DA-sensing molecules also show that HPC DA is elevated in a post-
meal state. These results were found using a mixed nutrient meal, and the proposed work will aim to parse
these HPC DA responses to isolated macronutrients, as well as to post-ingestive versus orosensory responses to
nutrients. Finally, Aim 3 seeks to build on previous findings in the lab revealing that diet induced obesity (DIO)
rat models have impaired meal location memory. We hypothesize that these memory deficits may arise from
aberrant expression of DAergic machinery in the HPC which may result in a blunted post-meal DA release.
Overall, improved understanding of the mechanisms underlying HPC DA signaling and the higher-order
control of food intake can elucidate the role of food reward and overeating behaviors associated with obesity.

Public health relevance
Project Narrative Over 40% of American adults are obese and, due to a lack of effective and affordable treatments for weight loss, the obesity epidemic remains a critical public health crisis. Novel and effective obesity prevention and treatment strategies are aided by basic science research identifying specific brain chemical systems that reduce food intake, and one hypothesis about obesity etiology is it is driven by impaired dopaminergic reward networks engaged during the consumption of highly palatable food. Here, we propose to investigate how dopamine signaling in the dorsal HPC is connected with the higher-order control of food intake and how presynaptic DA release and postsynaptic DA receptor signaling in this region may be impaired in models of obesity.